Personalization and Failure Testing of Dual Switch Gene Drives in Lung Cancer

Project Summary
Different patients with Non-small-cell lung cancers (NSCLC) can harbor mutations that result in constitutively
activated versions of tyrosine kinases (e.g. EGFR, RET, ALK, ROS1, TRK) that can be precisely targeted with
inhibitors. However, tyrosine kinase inhibitors are vulnerable to existing, known and unknown, drug resistance
mechanisms found in tumors. This results in a game of molecular “whack-a-mole” whereby, resistance evolution
appears, the mechanism is isolated, drugs are administered to combat that drug resistance, and then resistance
re-emerges until no effective therapies remain. This process of reverse engineering drug resistance has been a
losing battle with a high cost for patients. A promising approach to combat the challenge of resistance evolution
is to design and test cell therapies that can sense the therapeutic environment and respond through synthetic
biology circuits to reproducibly control evolutionary trajectories. We propose a synthetic biological technology
with proof-of-concept function in mammalian cells that we term “dual-switch selection drives”. These drives use
inducible drug resistance to create a cell therapy that can engineer a tumor’s evolution in situ. The first switch
senses the presence of a dimerizer molecule to create reversible drug resistance. Using the mathematical rules
of biophysics and evolution, our cell therapy calculates a response to small molecules and produces a tunable
amount of cellular fitness that competes with pre-existing drug resistance variants in a tumor. A second switch
with a suicide gene payload hitchhikes on this evolution guided cell therapy until the selection drive cells comprise
the majority of the tumor. Then, at the flip of a second switch, a locally diffusible toxin is produced that kills all
cells--gene drive or pre-existing resistance mutants of any molecular origin--through a bystander effect. This
technology works with the existing standard of care drugs in NSCLC to produce localized combination therapy
that can eradicate pre-existing resistance regardless of the molecular mechanism. Therefore, instead of
responding to and combatting evolution, we use forward engineering of cell therapies to direct evolution. In Aim
1 we will use nonintuitive insights from stochastic models of the evolutionary stability of our designs to propose
further optimized selection drives. Aim 2 expands our forward engineering approach by pushing our model driven
design of safety and efficacy towards the spatial, cellular, and microenvironmental heterogeneity present in
NSCLC. Aim 3 proposes to move evolutionary proof-of-concept experiments into primary human organoids from
NSCLC patients with activating mutations in EGFR. Beyond practical testing of a technology, we will also “build
to understand” the basic cancer biology of resistance evolution.

Public health relevance
PROJECT NARRATIVE Tyrosine kinase driven Non-small-cell lung cancers (NSCLC) develop resistance to tyrosine kinase inhibitors. Waiting for resistance, reverse engineering its molecular origins, and then responding to that resistance with new drugs is a slow, costly, and ultimately losing battle. This grant will propel the model driven forward engineering design of “dual-switch selection drives” in NSCLC that re-program tumor cells to work with existing therapies to combat drug resistance—regardless of molecular origin.